A randomized controlled trial of a preventive behavioral intervention for young adults with psychotic experiences

Project Summary
Psychiatric illnesses affect millions of Americans and can be associated with substantial emotional and
financial hardship for both those who are affected and their families. In fact, these illnesses are responsible for
a substantial portion of the disability associated with chronic medical conditions overall, in large part because
they 1) tend to be persistent or recurring throughout the lifespan, and 2) often lead to impairments in day-to-
day functioning. However, despite these well-known consequences of psychiatric conditions, there are still very
few validated, evidence-based, transdiagnostic interventions that are explicitly focused on the prevention of the
onset of these conditions and the associated disability. Thus, in this application, we propose to conduct a
randomized clinical trial of a four-session, group-based behavioral intervention called Resilience Training (RT)
that was previously shown in a randomized, waitlist-controlled trial to significantly reduce levels of subthreshold
symptoms of psychosis (often called “psychotic experiences” or PEs) and other transdiagnostic symptoms of
psychiatric illnesses in young adults (college students) with these symptoms. It has been well-established that
the presence of subclinical psychopathology including PEs is associated with an increased risk for the
subsequent development of a range of psychiatric illnesses, including psychotic, mood, anxiety and substance
use disorders, as well as suicidal behaviors and functional impairment. Therefore, in the proposed trial, we will
test whether RT leads to reductions in PEs and the distress associated with them, and reductions in anxiety,
depression and suicidality, in young adults with PEs, over a two year period. This trial will also investigate
whether RT leads to a reduction in emotion reactivity, a reflection of stress sensitivity, and improves the
functional connectivity and function of the hippocampus, a brain region involved in the body’s responses to
stress. Moreover, this project will evaluate whether RT positively impacts objective outcomes in college
students that reflect academic functioning and psychological health, including course credits earned, retention
in college and use of psychiatric crisis services, in addition to clinical outcomes, such as symptom levels and
the onset of psychiatric disorders. Lastly, the project will test whether the predicted mediating mechanisms of
RT (the reduction in emotion reactivity and improvements in hippocampal connectivity and function) are
responsible for any of its positive effects on functional and clinical outcomes. Overall, if the preventive efficacy
of RT is demonstrated, the results of this study will lay the foundation for dissemination of RT within a wide
range of communities where young people spend their time, on college campuses as well as in vocational and
employee training programs, primary care clinics, and work settings.

Public health relevance
Project Narrative The proposed research is a randomized controlled trial which will test whether a brief group-based behavioral intervention, called Resilience Training (RT), leads to sustained reductions in subclinical psychotic symptoms (“psychotic experiences”) and other transdiagnostic symptoms of psychopathology, and linked changes in emotion reactivity, hippocampal connectivity and hippocampal responses, when compared to a psychoeducational control condition. The study will also assess whether RT positively impacts objective functional outcomes and the onset of psychiatric disorders over time and whether the hypothesized linked psychological (emotion reactivity) and neural (hippocampal connectivity and responses) mechanisms of RT mediate its effects on these functional and clinical outcomes. If the predictions of this project are confirmed, follow-up work can begin to implement RT within college campuses and other communities of young adults, providing one evidence-based, transdiagnostic tool for addressing the worsening mental health crisis in this population.